The Role of a Pair of MAP3Ks in the Multicellular Response to Spinal Cord Injury

PROJECT SUMMARY / ABSTRACT
After spinal cord injury, a plethora of cellular responses impact functional recovery. Neurons may be preserved
or undergo cell death, axon degeneration and/or regenerative attempt. Astrocytes may become hypertrophic,
seal off the injury epicenter and influence axonal response in complex ways. Other cell types such as
fibroblasts/pericytes, microglia, macrophages also play important roles. Understanding how different cell types
respond to injury, how their responses are regulated and how they contribute to functional recovery is critical
for developing therapeutic intervention to promote functional repair after spinal cord injury. Regeneration is
axonal growth from injured neurons and sprouting is axonal growth from uninjured neurons. Both may
contribute to functional recovery. DLK and LZK are mammalian homologues of invertebrate DLK that has been
shown to play important roles in axon regeneration in C. elegans and Drosophila. The role of mammalian DLK
and LZK in spinal cord repair was not known. The goal of the parent R01 was to identify the neuronal (Aim 1)
and astrocytic (Aim 2) roles of DLK and LZK in axon and tissue repair after spinal cord injury. We have made
substantial progress on both fronts. This diversity supplement aims to support a graduate student from an
underrepresented background (an African American woman), who is asking the important questions on both
the direct and indirect roles of astrocytic LZK in tissue preservation and axonal repair after injury. Specifically,
the trainee will use a contusion injury model to assess the direct role of astrocytic LZK in tissue preservation
and injury site resolution along with functional recovery using genetic gain and loss of function analyses. She
will then profile the transcriptomic changes in the astrocytes using the RiboTag approach to discover potential
mediators of LZK signaling in astrocytes. Using methods to stimulate corticospinal axon regeneration, the
trainee will assess the effect of manipulating LZK-mediate astrocyte response on axonal repair. She will also
map the epistatic relationship between LZK and STAT3 in regulating the astrocyte response to injury. This
body of work along with the experimental techniques mastered in this process will propel the trainee to pursue
a career in independent neuroscience research that has both scientific and translational value in future. These
experiments complement the existing components in the parent R01 while remaining within the overall goal of
the original application.

Public health relevance
PROJECT NARRATIVE The proposed study will investigate the direct and indirect roles of astrocytic LZK in axon and tissue repair after spinal cord injury using genetic gain and loss of function analyses, experimental spinal cord injury and RNA sequencing. Such understanding will pave the way to develop therapeutic intervention targeting this pathway, thereby ultimately improving the quality of life for people with spinal cord injury or related neurological conditions. The training gained during this research will enable the diversity supplementee to pursue a research career in a field of neuroscience.